Crucial spinal circuit changes that mediate locomotor benefits and deficits following combined therapies after spinal cord injury

ABSTRACT
Severe spinal cord injury (SCI) often spares spinal circuitries innervating the hindlimbs but results in the loss of
motor control below the injury due to compromised descending innervation of the cord. Plasticity after injury
leads to the development of hyperreflexia and spasticity over time. Although hyperreflexia can be beneficial
initially, facilitating motor output and locomotor function, it disrupts functional gains in the longer-term. The
sensory afferents and their transmission within the cord are thought to be a primary mechanistic contributor to
both regained locomotor function and hyperreflexia following SCI. Thus, identification of the mechanistic balance
point between afferent input promoting locomotion and contributing to pathology, including hyperreflexia, after
SCI is crucial to maximizing functional recovery. During the prior funding period, we demonstrated that viral
delivery of brain derived neurotrophic factor (AAV-BDNF) below the lesion dramatically improves weight-
supported stepping in subsets of rats and mice with complete thoracic spinal cord injury but hyperreflexia
interferes with functional gains in other subsets over time. This provides a powerful experimental model where
the same treatment strategy leads to beneficial and detrimental outcomes. In this renewal application, we will
test the overarching hypothesis that spatial variations in plasticity and excitability across the cord due to viral
BDNF contribute to functional variation in both locomotor patterns and expression of pathological reflexes.
Experiments will be performed in two highly complementary neurophysiology labs with expertise in chronic
recordings and rehabilitation in rats and intracellular and genetics techniques in mice. To obtain precisely
controlled effects in spinal circuitry in both rodent models, we use complete SCI, eliminating descending control
driven effects below the lesion, and focusing on spinal and afferent driven plasticity. The complete SCI will
provide clean and unambiguous data which can subsequently guide other therapeutic work in more directly
clinically translatable animal models. Using mouse and rat data together, we will determine the structural,
synaptic, circuit, and synergy-related plasticity associated with the recovery of stepping, and interfering
hyperflexion and hyperextension, after complete SCI. Further, the critical windows and critical neural elements
supporting both locomotor improvements and the development of pathological reflexes will be determined. The
establishment of the structural, synaptic, and circuit differences underlying functional locomotor gains,
hyperflexion, and hyperextension will greatly contribute to mechanistic understanding of both function and
pathology, and has the potential to reveal testable structural or electrophysiological biomarkers for specific
pathologies. Additionally, the determination of timing, critical neuronal elements, and the mechanistic interactions
of these circuits with both AAV-BDNF driven plasticity and with epidural stimulation will together reveal key
therapeutic targets and potential neuromodulation-based treatment strategies to enhance locomotor function.

Public health relevance
NARRATIVE Results will shed light on the spinal cord changes following spinal cord injury (SCI) that are associated with functional improvements and pathological hyperreflexia or spasticity. Further, how the pathological outcomes can be prevented by epidural stimulation will be revealed. Such mechanistic insights will deepen our understanding of adaptive and maladaptive changes to spinal circuits after SCI, and will identify the therapeutic targets, windows of action, and interactions of therapies necessary in order to restore walking.